Unraveling the role of osteocytes in metabolic dysfunction associated with obesity

PROJECT ABSTRACT
The prevalence of obesity is on the rise and a better understanding of the drivers of this epidemic is
crucial. As novel insights implicate bone in regulating energy metabolism, it is crucial to understand how
diseases of positive energy balance, like obesity, affect the different functions of bone. While obesity is known
to impact the structural function of bone causing increased fragility, it is unclear how the metabolic function of
bone is compromised in obesity. Filling this gap in our knowledge is critical for developing therapeutics that can
reestablish energy metabolism while maintaining musculoskeletal health in obesity.
In this proposal, we explore the effects of obesity on bone regulated energy metabolism and focus
particularly on osteocytes, that constitute 95% of cells in bone. Our compelling preliminary data puts forth the
premise that TGFβ signaling is a key modulator of osteocyte-intrinsic energy metabolism (cellular). Thus, we
test the hypothesis that obesity impacts osteocytic TGFβ signaling that in turn contributes to deregulated
systemic energy metabolism. Furthermore, our data suggest that osteocytic TGFβ signaling also coordinates
the activities of epigenetic factors to shape the transcriptome of osteocytes. These epigenetic factors have
previously been implicated in obesity; however, their relation to TGFβ signaling and cellular energy metabolism
of osteocytes remains unexplored. Together, these findings motivate my central hypothesis, that osteocytic
TGFβ signaling drives metabolic dysfunction in obesity through an epigenetic mechanism. My aims to test this
hypothesis are to: 1) determine if obesity induces metabolic reprogramming in osteocytes in a TGFβ-
dependent manner, 2) determine if ablation of osteocytic TGFβ rescues metabolic dysfunction in
obesity, and 3) identify the function of TGFβ responsive epigenetic factors in regulating osteocyte
driven energy metabolism during obesity.
Using hyperglycemia and hyperlipidemia (in vitro) and DIO (diet-induced obesity, in vivo) to model
obesity, we will monitor the link between osteocytic TGFβ signaling, cellular- and systemic- energy
metabolism, and study its role in regulating the obesity-induced metabolic dysfunction. For combining ChIP-
Seq, ATAC-Seq, and RNA-Seq approaches, we will generate a network landscape connecting epigenetic
marks, modifiers, chromatin accessibility patterns, and corresponding molecular pathways that are impacted by
obesity in osteocytes. In the future, this landscape of molecular and epigenetic networks will serve as a
blueprint that can be used to interpret osteocyte function in metabolism in response to distinct nutrient cues.
Such a blueprint will be particularly informative in devising or predicting outcomes of pharmacologic
interventions and will lay the foundation for my independent research that dissects the intricacies behind the
crosstalk between bone function and energy metabolism.
Project Abstract

Public health relevance
PROJECT NARRATIVE Obesity-induced metabolic deregulation is linked to increased bone fragility. However, bone is also a crucial driver of energy metabolism, yet the impact of obesity on the bone’s metabolic function remains unclear. Here, we test the possibility that obesity disrupts osteocyte-intrinsic energy metabolism that in turn contributes to deregulation of systemic energy balance. Testing this hypothesis will advance our understanding of the cellular and molecular mechanisms that mediate the crosstalk between bone and metabolic tissues, which will improve the success of clinical efforts to reestablish energy balance while protecting musculoskeletal health in obesity. Project Narrative